Cancer Care Companion: An Electronic Health Record Tool to Improve Information Exchange and Self-Management in Pediatric Cancer

Project Summary
High-quality communication between clinicians and parents is critical to providing optimal care for pediatric
cancer. Yet, almost no communication interventions exist in pediatric cancer. To address parents’ unmet
communication needs after diagnosis, it is imperative to develop an effective, parent-centered, and scalable
communication tool specific to the needs of families affected by pediatric cancer. This study proposes to
engage parents of children with cancer to develop and pilot an electronic health record (EHR)-based
communication tool using participatory design methods. To ensure this tool is useful, feasible, cost-effective,
and designed for dissemination, the investigators will co-develop an EHR tool that adapts the existing Epic
MyChart Care Companion to meet the needs of children with cancer and their families. Care Companion is an
interactive, highly adaptable Epic MyChart add-on that can incorporate video- and text-based educational
materials, symptom surveys, and links to initiate portal messages. The study team found that 74% of children’s
hospitals use Epic EHR, which will support broad dissemination of this Cancer Care Companion. This study
will fulfill the following aims. Aim 1: To develop, refine, and prioritize content and functions to be incorporated
into the Cancer Care Companion, in partnership with parents of children with cancer and pediatric oncology
clinicians. The study team will facilitate 6 participatory design workshops with 6 to 8 participants per workshop.
The team will host 2 workshops for clinicians and 4 for parents. Each workshop will include 2 stages: discovery
and prototyping. The team will identify essential topics for informational materials, sources of high-quality
information, pertinent symptoms to track, and appropriate clinical workflows. The team will purposively sample
for 25% of parents from racial and ethnic minorities for participation in design sessions. In collaboration with
the St. Louis Children’s Hospital Epic Build Team, the team will build the Cancer Care Companion. Aim 2: To
pilot and evaluate the Cancer Care Companion at St. Louis Children’s Hospital with up to 40 parents of
children with cancer. The investigators will assess the feasibility, acceptability, and appropriateness of the
Cancer Care Companion among parents of children with newly diagnosed cancer. After 3 months of use, the
team will perform qualitative interviews with parents to assess their positive and negative experiences and
possible modifications to improve the tool. The team will track utilization and administer validated measures to
assess the tool’s acceptability, appropriateness, and feasibility. This proposal aligns with research priorities of
the National Cancer Institute and addresses the critical need for high-quality communication in pediatric
cancer, especially near the time of diagnosis. Findings from this study could serve as a model communication
tool for long-term cancer survivors or other serious pediatric illnesses. These findings will also be essential to
support a future multicenter clinical trial.

Public health relevance
Project Narrative High-quality communication between clinicians and parents is critical to providing optimal care for pediatric cancer. Yet, almost no communication interventions exist in pediatric cancer. This study proposes to engage parents of children with cancer to develop and pilot an electronic health record (EHR)-based communication tool using participatory design methods.